Identification of next generation gamma-secretase modulators for Alzheimer's disease

Abstract
Alzheimer’s disease (AD) is the most common form of senile dementia. An estimated 6 million Americans are
affected, and this number is increasing yearly. Currently, there is no cure for AD; however, it is widely accepted
that inhibiting amyloid plaque formation would be beneficial for the prevention of Alzheimer’s disease. Although
there are many approaches for the treatment of AD, one novel and innovative approach is to modulate the activity
of the key enzyme complex involved in Aβ42 production (a primary component of amyloid plaques), γ-secretase
(GS). Because of the potential for serious side-effects associated with inhibition of GS, modulation of its activity
was targeted in order to avoid non-specific effects on other γ-secretase substrates such as the Notch, an
essential element for normal cellular development. Our scientific approach will focus on the next generation of
γ-secretase modulators (GSMs), identified and selected based while using ligand and structural based drug
design. Medicinal chemistry followed by in vitro and in vivo optimization efforts will lead to the identification of
novel lead compounds with lowering of Aβ42 both in vitro and in vivo while promoting the formation of smaller,
potentially less toxic Aβ peptides (Aβ37 and Aβ38) without altering the activity of γ−secretase toward other
substrates such as Notch. In this proposal, we plan to identify compounds for modulating Aβ peptides with
excellent absorption, distribution, metabolism, and safety properties to gain a large therapeutic index. These
studies are expected to aid in the choice of a candidate to pursue pre-clinical studies.
1

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a progressive, neurodegenerative condition that causes memory loss, confusion, cognitive decline, and behavioral changes. AD is the most common form of dementia in the elderly burdening as many as 1 in 8 people above the age of 65. Based on the large number of affected Americans- estimated at more than 6.7 million for 2024-- and the enormous cost to society-- in the billions-- the need for effective early prevention and treatment is compelling. 1